Strategies and Therapies for Outcomes Prevention in Cirrhosis: The STOP-C Liver Cirrhosis Network

Project Summary/Abstract:
Cirrhosis and its complications including hepatocellular carcinoma (HCC) are increasingly common causes of
morbidity and mortality in the United States. The central hypotheses of this application are that (1) the creation
of a prospective cohort study of patients with compensated cirrhosis will facilitate the generation of novel
prediction models based on the clinical, behavioral, metabolic, and biomarker data we collect to predict clinical
decompensation, (2) this cohort can validate and then be supplemented by a larger electronic health record
(EHR)-based virtual cohort, the latter of which will enable validation of electronic cirrhosis phenotypes and
subsequent analysis of real-world data on the safety and effectiveness of individual lipid-lowering agents on
multiple outcomes among patients with cirrhosis and (3) long-term statin therapy will provide clinical benefits in
preventing hepatic decompensation and HCC independent of its lipid lowering effect. To investigate these
hypotheses, we propose unique approaches to both the cohort study and statin-based clinical trial for the Liver
Cirrhosis Network (LCN). In Aim 1a, we will create a prospective cohort of highly phenotyped patients with
compensated NASH, ALD, cholestatic and cryptogenic cirrhosis, in order to facilitate the interrogation of
biospecimens, patient reported behaviors and outcomes, and clinical data for novel predictors of disease
progression, and to understand through serum lipoproteins measurement the complex interaction between
cirrhosis and lipid metabolism. In Aim 1b, we will create a large LCN-wide EHR-based virtual cohort of patients
with compensated cirrhosis, prospectively validate electronic phenotypes for cirrhosis and its clinical
complications with our in-person cohort, and evaluate the use, safety and effectiveness of different classes of
lipid lowering medications upon outcomes in this large real-world virtual cohort. In Aim 2, we propose to study
the safety and efficacy of statins in preventing clinical decompensation among patients with NAFLD or ALD
cirrhosis while exploring the potential pleiotropic mechanisms of statins. In this trial, patients with and without an
established non-hepatic indication for lipid lowering will be randomized to pravastatin v. alirocumab (stratum 1)
or placebo (stratum 2), respectively. This innovative approach to the statin-based clinical trial will acknowledge
the patient's baseline indication for lipid-lowering therapy, and offer an alternative lipid lowering pathway in
PCSK9 inhibition, which has similar or greater LDL-lowering potency but lacks the pleotropic effects of statins,
to allow for novel insights into mechanisms by which statins might impact outcomes independent of its effects
on lipids. Throughout the cohort and interventional trials, we will study lipoprotein metabolism, inflammatory
markers, and collect microbiome and biospecimens for future translational research to better understand the
mechanisms behind disease progression in cirrhosis and for any potential impact of pravastatin and alirocumab
on clinical outcomes. These innovative strategies therefore leverage both cohort and clinical trial designs to
maximize the knowledge gained and improve clinical outcomes among patients with cirrhosis.

Public health relevance
Project Narrative The proposed research is relevant to human health because patients with cirrhosis of the liver are at risk of liver disease progression, liver cancers and death, and treatments as well as the ability to identify patients at the highest risk of complications are lacking. In this application to be a clinical center in the Liver Cirrhosis Network, we propose to develop a prospective cohort to identify new ways to determine the risk of disease progression in patients with cirrhosis, and to test whether the medications pravastatin or alirocumab decrease this risk. The execution of these studies collaboratively throughout the Liver Cirrhosis Network will be crucial to understanding how patients with liver disease progress and how we can improve outcomes in this population in need.